Continuation of Cooperative Agreement between U.S. Food and Drug Administration and S.C. Department of Health and Environmental Control (DHEC) for MFRPS Maintenance.

Project Summary/Abstract - DHEC MFRPS Maintenance Track
FOA Number: RFA-FD-23-027; Application ID: 1407708
Overall Component, Research and Related Other Project Information Form #7
If this cooperative agreement is awarded, the South Carolina Department of Health and
Environmental Control (DHEC) will strive to maintain its status of full conformance with
all ten Manufactured Food Regulatory Program Standards (MFRPS) under the MFRPS
Maintenance Track. Fulfilling the overarching, broad objectives of this Funding
Opportunity Announcement (FOA) is essential for the realization of DHEC’s visions:
utilizing standardized approaches for food industry regulation, protecting public health,
and securing the safety of South Carolina’s food supply.
Through our FDA Assessments, DHEC achieved full implementation of all 10 MFRPS in
2017, achieved full conformance with all 10 MFRPS in 2019, and maintained full
conformance with all 10 MFRPS in 2021. During this cooperative agreement, DHEC will
be completing maintenance tasks to meet the annual goals for the MFRPS Maintenance
Track of this FOA. These routine tasks include, but are not limited to, self-assessments,
policy and procedure revisions, continuing education, monitoring inspections and audits,
identifying chronic violations and violators, and attending outreach activity events. All
identified gaps in conformance will be swiftly addressed using Corrective Action
Preventive Actions (CAPA) in our Strategic Improvement Plan (SIP).
To achieve the overarching goal of MFRPS Maintenance, DHEC’s MFRPS Coordinator
and MFRPS Assistant will work together to maintain an up-to-date Strategic
Improvement Plan (SIP), a keystone part of MFRPS Maintenance, and to maintain
records of and continue monitoring training, inspections, sample collections, equipment
verifications, consumer and industry complaints, audits, foodborne illness outbreaks,
enforcement actions, chronic violators, chronic and critical violations, outreach events,
equipment purchases, and staffing changes.

Public health relevance
Project Narrative - DHEC MFRPS Maintenance Track FOA Number: RFA-FD-23-027; Application ID: 1407708 Overall Component, Research and Related Other Project Information Form #8 The South Carolina Department of Health and Environmental Control (DHEC) has achieved full conformance with all ten Manufactured Food Regulatory Program Standards (MFRPS); this has vastly improved the extensiveness and quality of our manufactured food regulatory program in all areas of our program related to MFRPS. During this cooperative agreement, under the MFRPS Maintenance Track, DHEC will continue the use of standardized/shareable approaches for completing maintenance tasks for all ten MFRPS. This will ensure we maintain conformance with the MFRPS and continue to meet the required critical elements for an integrated food safety system.